Exploring the role of T cells in protection from respiratory virus transmission

PROJECT SUMMARY / ABSTRACT
Respiratory viruses remain a major threat to human health, and the development of novel approaches to promote
durable protective immunity against both severe disease and viral transmission are sorely needed. Respiratory
virus infection and intranasal immunization generates antigen-specific T cell and B cell memory throughout the
respiratory tract. This includes a population of tissue-resident memory T cells (TRM) that are uniquely positioned
within the mucosa to rapidly recognize and respond to re-exposure with a similar pathogen. Often these TRM are
specific for highly conserved epitopes that are shared across many viral strains and can therefore provide
protection against viral variants. Recently, using a model of natural respiratory virus transmission we
demonstrated that CD8+ TRM are sufficient to rapidly identify and eliminate rare, infected cells prior to propagation
of the infection. However, the distinct TRM subsets and cell-intrinsic antiviral mechanisms that are important for
limiting transmission are unknown, and how these mechanisms impact local epithelial cells to inhibit viral
propagation are not well characterized. To address these deficiencies, we propose to use a murine model of
Sendai virus transmission to define the cellular interactions and molecular mechanisms that promote TRM-
mediated protection against transmission. Finally, we have developed a guinea pig model of influenza virus
transmission to investigate the efficacy of T cell-mediated immunity in limiting transmission of a relevant human
pathogen. Identifying the characteristics, cellular interactions, and molecular mechanisms of respiratory tract TRM
that protect against natural respiratory virus transmission will provide key information for the rational design of
future cell-mediated vaccine against respiratory pathogens.

Public health relevance
PROJECT NARRATIVE Respiratory viruses continue to constitute a major threat to human health, and there is an urgent need to investigate additional strategies that induce durable immunity which is more resistant to viral escape. This proposal seeks to define the cellular interactions and molecular mechanisms by which respiratory tract-resident memory CD8+ T cells protect against natural respiratory virus transmission. Our findings will provide valuable insights for the future development of cell-mediated vaccines designed to provide broad protection against diverse viral strains and limit the spread of respiratory viruses in the population.